Regulatory mechanisms of mitochondrial cristae biogenesis and thermogenic function

Abstract
Metabolic diseases include obesity and type 2 diabetes (T2D) are associated with exacerbated health risks that
can be life threatening such as heart complications, viral infections, or cancer. Current therapies to treat obesity
are based on exercise, diet, and/or bariatric surgery that not always are possible or succeed due to genetic
components, non-compliance, or excessive cost. There is a need to understand the mechanisms that sustain
energy balance to provide more efficient and cost-effective therapies. Activation of adaptive thermogenesis is
an attractive approach to combat obesity/T2D. Increased thermogenic and metabolic function in response to
lower temperatures or high calorie diets occurs, at least in part, in specialized fat cells, brown and beige
adipocytes. Adult humans possess mitochondria-enriched beige-like adipocytes that display molecular
signatures resembling murine beige fat and can be reactivated by cold or b3 agonists causing metabolic benefits.
Thermogenic activity in specialized adipose cells depends on the fitness of mitochondrial organelles carrying
uncoupling respiration or futile reactions that dissipate energy as heat. Mitochondrial respiration occurs in
organized structures called cristae, tubular invaginations of the inner mitochondrial membrane that function as
battery-like devices generating and dissipating energy. We have identified a new cold stress inducible
mechanism that controls mitochondrial cristae assembly and thermogenic activity in brown/beige adipose cells.
Components of this thermogenic regulatory mechanism include the cold- and adrenergic-activated ER resident
kinase PERK that signals to mitochondrial protein import machinery facilitating assembly of MICOS complexes
that organize and promote cristae biogenesis. In vitro and in vivo studies show that adipose PERK deficiency
results in defective cristae formation and impaired thermogenic responses. The premise of this application is
that the ER signals to the mitochondrial protein import to control cristae biogenesis and form competent
thermogenic adipocytes protecting against lower temperatures and obesity/T2D. We have three aims: 1)
determine the regulatory mechanisms of cristae biogenesis and thermogenic function through PERK activation,
focusing on how PERK controls cristae formation including activation of OGT-dependent glycosylation; 2)
determine the mechanisms of cold-dependent mitochondrial protein import coupled to thermogenic function,
investigating co-chaperones and TOM70-assisted MIC19 protein import that causes cristae biogenesis and
thermogenic function, and 3) analysis of mitochondrial cristae formation and metabolic/energetic function during
cold- and diet-induced thermogenesis using genetic mouse models, focusing on how different this signaling ER-
mitochondria axis impacts energy balance and metabolism during cold adaptation and high fat diet feeding. The
outcomes of this application will determine the regulatory mechanisms that control thermogenic mitochondrial
cristae biogenesis in response to lower temperatures and excess calorie intake. These regulatory mechanisms
have important implications in metabolic diseases including obesity and T2D and related clinical complications.

Public health relevance
Project Narrative The studies in this grant proposal address the molecular mechanisms of mitochondrial cristae biogenesis and respiratory/thermogenic function in specialized brown and beige adipocytes. These mechanisms are central to our understanding of energy balance linked to obesity and type 2 diabetes.